Structural mechanisms of sliding clamp loader ATPases

Project Summary/Abstract
All life forms require a ring-shaped sliding clamp for copying their genome. These sliding clamps
act as master regulators of DNA replication, coordinating replisome action with other cellular
processes. These master regulators are themselves regulated by large ATPase machines called
clamp loaders that either install or remove sliding clamps from DNA. This project seeks to gain
an atomic-level understanding of clamp loader mechanism. These protein remodeling machines
open the sliding clamp ring as a key step in their action. We have found that in the key
intermediate of open clamp, ATP-bound clamp loader and DNA, the protein components form a
spiral that matches the helical symmetry of DNA. This symmetric spiral activates ATP hydrolysis
leading to clamp closure and release of the clamp. In Aim 1, we now turn our attention to the
critical first two steps of the reaction: opening the clamp, and then binding DNA to the inner
chamber of the complex. We will identify the conformational changes in the clamp loader
complex that allow for opening the clamp ring, as well as how the assembly can rapidly bind a
specific DNA structure in the tight confines of the complexes’ interior. In Aim 2, we investigate
how the single subunit change in the clamp loader complex (Rfc1 replaced with Elg1) can
convert a dedicated clamp loader into a dedicated unloader. This work will not only reveal the
mechanism and structure of a key protein involved in cancer development, but will also provide
a blueprint for how an ATPase machine can be programmed to perform the reverse reaction.
Finally, in Aim 3 we explore how replacement of the Rfc1 subunit with Ctf18 leads to an
assembly that connects DNA replication to the process of sister chromatid cohesion and is
bifunctional as both a loader and unloader. Our structures and analysis of this complex will
reveal how an ATPase machine can be mechanistically flexible to catalyze both forward and
reverse reactions. In addition, this work will provide insight into how this mysterious complex
can link the seemingly disparate processes of DNA replication and sister chromatid cohesion.
Because clamp loaders and sliding clamps are fundamental to all life, the structural insights we
obtain from completing our aims will be invaluable for developing strategies for novel
antimicrobial or chemotherapeutic drugs.

Public health relevance
Project Narrative Sliding clamps are proteins that are critical to the copying of DNA. These ring-shaped proteins are installed or removed from DNA by clamp loaders. Sliding clamps and clamp loaders are important for cellular proliferation and cancer development. We will uncover how sliding clamps are put onto or removed from DNA. We will determine these processes in atomic detail. This work will provide an understanding of how nature’s nanomachines have evolved to do mechanical work, and will also provide a blueprint for how to target sliding clamp loaders for chemotherapy or antimicrobial therapy.